Nanoformulated small molecule immunotherapy for SHH medulloblastoma

Nanoformulated small molecule immunotherapy for SHH medulloblastoma
M. Sokolsky-Papkov, (PI)
This project focuses on improving therapy of medulloblastomas. Despite aggressive and highly toxic multi-modality
therapy, 30% of the children diagnosed with medulloblastoma will still die from recurrent disease. The survivors have
increased risk for subsequent neoplasms and are often left with severe and lifelong treatment-associated cognitive and motor
deficits. Development of novel modalities that are more effective and safer than the current therapies is paramount in
improving the clinical outcomes in medulloblastomas. Cancer immunotherapy, the utilization of the patients’ own immune
system to treat cancer, has emerged as a powerful new strategy in cancer treatment. A recent study by our collaborator, Dr.
Dolores Hambardzymyan, suggested that SHH medulloblastomas are enriched in TAMs and our data shows that these
TAMs express TLR7/8. An imidazoquinoline drug resiquimod [R848], a Toll-like receptor (TLR) 7 and 8 agonist, is
evaluated as a single agent or adjuvant in combination with vaccines is several oncology clinical trials in patients with
melanoma, bladder cancer, glioma, and other malignancies (ClinicalTrials.gov: NCT00470379, NCT00821652,
NCT00960752, NCT01204684). However, resiquimod is nearly insoluble at neutral physiological pH, and there is no
clinically approved formulation available for its systemic or local intratumoral administration. We have loaded resiquimod
into our ultrahigh-capacity nanoparticle polymeric micelles (PMs) platform. Previously we have utilized this platform to
deliver SMO inhibitor vismodegib, CDK4/6 inhibitor palbociclib and PIK3/AKT/mTor inhibitor Sapanisertib (INK-128).
Delivery in POx PMs reduced toxicity and rendered these agents effective, while free drugs showed no survival benefit in
G-Smo mice-genetically engineered mouse model (GEMM) of SHH medulloblastoma. Unlike cells based or patient derived
implantable models these mice have endogenous tumors which form intact native tumor environment and blood brain barrier
(BBB). Treatment with POx-resiquimod PMs (POx-Res PMs) significantly enhanced infiltration of macrophages into the
tumors decreased tumor cells viability (pRB levels) and prolonged mice survival. This project aims to obtain mechanistic
data to evaluate the effects of POx-res PMs administered systemically (IP) and locally (IT) and determine whether the anti-
neoplastic agents that target SHH pathway can synergize with POx-res PMs to improve treatment outcomes. Specific aims
are: 1. Delineate systemic vs. local effects of POx-res PMs on the tumor immunological status, disease progression, and
therapeutic outcomes in GEMM model of SHH medulloblastoma. 2. Delineate the contributions of immune cell populations
to the therapeutic effect of POx-res PMs and 3. Determine whether the anti-neoplastic agents that target SHH pathway can
synergize with POx-res PMs to improve treatment of SHH driven medulloblastoma.

Public health relevance
PROJECT NARRATIVE This project focuses on improving treatment of a pediatric brain cancer, medulloblastoma, that despite aggressive treatments kills 30% of the children from recurrent disease and often leaves the survivors with severe and lifelong treatment-associated cognitive and motor deficits and at risk of subsequent neoplasms. We will use small-molecule toll-like receptor 7 and 8 agonist, resiquimod, packaged in innovative nanoparticles to deliver resiquimod to the tumor, remodel tumor microenvironment and promote antitumor immune response. This project will determine mechanisms of immunotherapy using our novel therapeutic modality and asses its potential in combination with antineoplastic agents to improve treatment outcomes in medulloblastoma.